Algorithms and Software for Biomolecular Structure Determination at the Proteome Scale

Project Abstract
Algorithms and Software for Biomolecular Structure Determination at the Proteome Scale
One of the central tenets of structural biology is that the direct observation of molecules at the atomic
level can reveal the function and mechanism of the biomolecular machines that are responsible for life.
Recent advances in cryo-electron microscopy (cryo-EM) and tomography (cryo-ET) have revolutionized our
ability to study these biomolecular machines, enabling the production of atomic resolution structures of large
complexes and visualizing their native conformations and structural context in situ. These techniques hold
great promise for resolving the conformational and structural heterogeneity intrinsic to the function of these
biomolecules. However, the low throughput and limited scope of current methods hinder our ability to study
the vast diversity of biomolecular structures and interactions across entire proteomes.
In this proposal, we aim to develop novel artiﬁcial intelligence (AI) and machine learning (ML) methods
to address critical challenges in cryo-EM and cryo-ET image processing. Our goal is to advance a new
paradigm of structure determination that can operate at the proteome scale, enabling high-throughput and
high-resolution analysis of complex biological systems. Speciﬁcally, we propose to integrate prior structural
information from sequence and structural databases with cryo-EM and cryo-ET data, leveraging the strengths
of both data-driven and knowledge-based approaches. By designing forward models that incorporate
geometric information about the underlying protein structures and developing multimodal generative models
that can generalize across diverse biomolecular complexes, we aim to signiﬁcantly enhance the accuracy and
eﬃciency of biomolecular structure determination. From this research, we will create open-source software
tools and release curated datasets to support downstream tasks in machine learning for biology. The
successful implementation of this proposal will facilitate the emergence of visual proteomics, transforming the
current paradigm of reductive structural biology which focuses on individual targets. By enabling
comprehensive analysis at the proteome scale, this work has the potential to fundamentally change our
understanding of subcellular processes and lead to new discoveries in the molecular mechanisms underlying
health and disease.

Public health relevance
Project Narrative Structural biology provides invaluable insights into the molecular mechanisms underlying health and disease, but its low-throughput nature limits the speed and scope of discoveries. This research aims to develop AI algorithms and software that leverage machine learning to enable biomolecular structure determination at the proteome scale. By enabling high-resolution visualization of complex protein structures across entire proteomes, this work will advance our understanding of cellular mechanisms and contribute to new approaches in drug discovery and disease treatment.